Evaluation of the Smart Talk: Cannabis Awareness and Prevention Curriculum

Project Summary/Abstract
Cannabis is the most widely used illicit drug among adolescents ages 14 -18 in the United States. Research
demonstrates cannabis use is not harmless, especially given that the adolescent brain is particularly
susceptible to dependence, and due to cannabis-related risks to the lungs, increased risk for depression, and
decreased academic performance. Despite these health risks, since the mid-2000s, adolescents’ perceived
risk of cannabis use has declined, and adolescents’ approval of cannabis use has increased. To date, very few
comprehensive programs addressing adolescents’ misperceptions and knowledge about cannabis and
preventing and reducing the use of all cannabis products have been developed, evaluated, or widely
disseminated throughout the U.S. To address this gap, using a community-based participatory research
approach in which we included a large group of adolescents and young adults, parents, educators, and
healthcare providers with expertise in addiction medicine, we developed the “Smart Talk: Cannabis Prevention
& Awareness” (Smart Talk) curriculum, which includes 5 lessons focused on health and environmental affects
of cannabis, marketing, stress and coping, and refusal skills. Aligning with the NIH Stage Model for Behavioral
Intervention Development, and through an NIH R34 grant in which we conducted a pilot randomized control
trial with six schools, we have addressed 3 of the 6 stages needed to adequately develop, evaluate, refine, and
fully implement and disseminate our Smart Talk curriculum. Our next step is to conduct a full evaluation to
determine the real-world efficacy and effectiveness of the Curriculum (Stages III-IV), to determine for whom the
Curriculum is most and least effective, and to further implement and disseminate the Curriculum (Stage V). As
such, using a cluster-randomized trial, stepped-wedge design, with 30 middle and 30 high schools in California
and New York (n=10,800 students), the Specific Aims of this proposed project are to: (1) Determine whether
the Smart Talk Curriculum is effective in increasing adolescents’ knowledge of the different forms of cannabis
and resistance to using and decreasing their positive attitudes towards and intentions to use cannabis
products; (2) Determine whether the Smart Talk Curriculum is effective in changing adolescents’ actual use of
different forms of cannabis (including preventing initiation, continuation, escalation; encouraging decreased
use and cessation; and reducing co-use of cannabis and tobacco use); and (3) Examine the heterogenous
treatment effects (HTE) of the intervention, identifying both those who benefit the most and those who do not
benefit from the curriculum. The timing of this proposed research is extremely important given the rates of
cannabis use in adolescence, legalization of cannabis across the country, and need for comprehensive
cannabis education and prevention programs. Already we have hundreds of schools implementing Smart Talk,
so determining the real-world effects of the curriculum and revising the curriculum as needed will further
address the needs of schools and adolescents.

Public health relevance
Project Narrative Cannabis is the most widely used drug among adolescents aged 14-18 in the United States. However, few programs focusing on prevention and de-escalation of all cannabis products have been developed, tested, or widely disseminated throughout the U.S. We developed Smart Talk: Cannabis Prevention and Awareness Curriculum, a school-based curriculum aimed at changing middle and high school students’ attitudes towards, misperceptions about, intentions to use and actual use of cannabis products, which will be evaluated for changes in adolescents’ knowledge, attitudes, intentions, and actual use.